Administrative Core

Summary – Administrative Core
The Administrative Core of this research program will provide a framework for successful completion of the
proposed work, ensuring that collaboration and scientific interactions among the Projects and the Modeling Core
are rich and innovative. The research program involves the Siliciano lab at Johns Hopkins studying reservoir
dynamics in people living with HIV, the Barouch lab at Harvard study prevention and cure of HIV infection in non-
human primate models, and the Perelson group at Los Alamos National Lab studying mathematical models of
viral infection. The Core will facilitate existing interactions between these geographically dispersed groups
through a shared database, monthly joint virtual lab meetings, and an annual in person meeting.